Washington University PDX Development and Trial Center

OVERALL PROJECT SUMMARY/ABSTRACT
The myriad of both newly-available molecular targets and novel anti-cancer agents has underscored the crucial
need to develop preclinical models in order to optimize clinical trial design. Several technical benefits make
patient-derived xenograft (PDXs) models particularly attractive for drug testing and personalized medicine.
Biologists and physicians at Washington University School of Medicine (WUSM) and the Siteman Cancer Center
(SCC) developed and operated the Washington University PDX Development and Trial Center (WU-PDTC) as
part of the PDXNet program during a prior funding period (CA224083) from 2017-2022. Based on the success
of this program, we propose to renew WU-PDTC funding as a T-PDTC with the goal of continuing our efforts in
preclinical testing and prioritizing and studying unmet needs in cancer in this collaborative, nation-wide effort.
The PDX Core within WU-PDTC will develop and characterize 400 new PDX models across major tumor types.
These models will be characterized using the latest omics technologies and analyzed using the most current
bioinformatics pipelines that have been deployed for PDXNet and other large scale NCI programs. Tumors
representing unmet needs and priority areas for collection will be emphasized (e.g. treatment resistant cancers).
The Bioinformatics Core will integrate these analyses with clinical annotation from the originating patient to
include treatment history and tumor response (Aim 1). Our two Research Projects will conduct PDX clinical trials
of single and combination agents using drugs in the NCI CTEP portfolio (Aim 2). Project 1 will investigate
predictive biomarkers and resistance mechanisms for DS-8201a alone and in combination with DDRi in breast
cancer (expanding to GI and lung cancers), while Project 2 will study targeting the onco-inflammatory circuitry in
combination with anti-KRAS and chemotherapies in GI and lung cancer (this will expand to breast cancer).
Proteogenomic, imaging, and clinical response data will be collected for these models as part of a broader effort
of characterizing PDX models and conducting clinical correlation and treatment response analyses by the
Bioinformatics Core (Aim 3). Proteogenomic features of PDX models and treatment/response histories will be
tracked using our well-established WU-PDXdb that will be accessible to PDXNet and PDMR-FNLCR. In Aim 4,
the WU-PDTC will leverage existing expertise and programs from Siteman Cancer Center (SCC), Institute of
Clinical and Translational Research (ITCS), McDonnell Genome Institute (MGI), Mallinkrodt Imaging Research
Center (MIRC), and Early Therapeutic Clinical Trials Network (ETCTN) to support the goals of developing and
utilizing PDX models to test and improve cancer treatment, in collaboration with other components of PDXNet.
Finally, WU-PDTC, through coordination by the Administration Core, will support Pilot Projects utilizing these
PDX resources to foster collaboration across PDTCs, PDMR-FNLCR, and other NCI programs (Aim 5). In
summary, the goals are to increase the spectrum of agents tested in PDX clinical trials and to improve the
reliability, validation, utility, and standardization of PDX models through innovative cross-PDXNet research.

Public health relevance
OVERALL PROJECT NARRATIVE Cancer is a complex and heterogenous disease that can arise from somatic and/or germline predispositional events in driver genes/pathways. Because of complex resistance and relapse mechanisms, combination therapies are generally viewed as necessary to improve the outcomes of patients with advanced malignancies. PDX models provide a platform for large-scale testing of combinations, allowing both identification of promising therapeutic regimens for future clinical trials and deeper investigation of the mechanisms governing therapy response and resistance.